TGF-beta Signaling Mechanisms in C. elegans Physiology and Homeostasis

Project Summary
The Transforming Growth Factor beta (TGF-β) family of secreted peptide growth factors plays significant roles
in cell function, tissue patterning, and organismal homeostasis. Dysregulation of TGF-β signaling pathways is
associated with many diseases and disorders, including cancer, cardiovascular disease, and developmental
disorders. These ligands can be divided into bone morphogenetic protein (BMP) and TGF-β/Activin subfamilies
that predominantly signal through discrete signaling pathways composed of heterotetrameric receptors and
Smad signal transducers. Many of the ligands have context-dependent and/or concentration-dependent
functions. BMPs are best known for their roles in development, but evidence is emerging for their roles as
regulators of homeostasis. While the core components of TGF-β signaling pathways have been identified for
more than 25 years, how these pathways produce context-dependent outcomes remains poorly understood. In
the nematode Caenorhabditis elegans, there are only five TGF-β ligands, two type I receptors, and one type II
receptor, providing an opportunity to dissect ligand-ligand and ligand-receptor interactions in a smaller number
of combinations than in vertebrates. Our preliminary data have established that DBL-1/BMP functions in lipid
metabolism and in innate immunity through mechanisms that are distinct from its roles in development.
Furthermore, we identified a role for TIG-2 (BMP-like) and TIG-3 (TGF-β/Activin-like) in the immune response
that may be mediated by the BMP-responsive Smad SMA-3. We are therefore poised to exploit this system to
identify context-dependent mechanisms that distinguish these physiological outcomes from the developmental
functions of signaling. Our research goals are to address these unanswered questions: (1) What are the
determinants of signaling specificity for TGF-β-related signaling pathways? Hypothesis: Alternative
ligand-ligand and ligand-receptor interactions are a mechanism for context-dependent responses. (2) How
does BMP signaling execute its fat-regulatory function at the subcellular and molecular levels?
Hypothesis: Genetic suppressors of the low-fat phenotype of dbl-1 mutants will reveal regulatory networks that
interact with BMP signaling to modulate fat storage. (3) Does altered lipid metabolism impact resilience to
pathogen exposure? Hypothesis: BMP-dependent mobilization of lipid stores contributes to survival on
pathogenic bacteria. Our established assays for fat accumulation and pathogen survival provide whole-
organism functional assessments for signaling. We will employ classical genetics, imaging, genomics, and
biochemistry to test our hypotheses at a mechanistic level. This integration of approaches, combined with the
reduced quantitative complexity in TGF-β signaling components, makes C. elegans the ideal model to address
these gaps in knowledge. Due to the high degree of conservation of TGF-β signaling pathways, we anticipate
valuable insight into universal mechanistic principles with implications for human health and disease.

Public health relevance
Cellular communication initiated by members of the Transforming Growth Factor beta (TGF-β) family of secreted signaling molecules plays important roles in normal and pathological biological processes. Signaling components mediate diverse outcomes that depend on the context, but how these outcomes are differentiated is poorly understood, increasing the likelihood of causing unintended consequences during the management of diseases and disorders. In this project, we will exploit the advantages of a simple model organism to uncover the conserved mechanisms that distinguish the roles of TGF-β signaling in fat metabolism and immunity from those in development.